Studying The Mechanisms of Delayed Lung Injury Post-Arsenical Exposures

Title: Studying The Mechanisms of Delayed Lung Injury Post-Arsenical Exposures
Abstract
In this study, we aim to investigate the mechanisms of delayed lung injury after a single exposure to trivalent
arsenic chemical agents: Lewisite, Phenyl arsenic oxide, and arsenic trioxide. Our research using murine
models has shown that skin exposure to Lewisite and Phenyl arsenic oxide, as well as single inhalation
exposure to arsenic trioxide, leads to persistent systemic inflammation and fibrotic airway-centered chronic
bronchitis. Additionally, in our model, we observed that single exposure to arsenic trioxide exposure led to
hemolytic anemia-like lung disorder. We hypothesize that trivalent arsenic injury triggers the release of self-
double-stranded DNA in the form of NETs, which activate IRF7 in airway epithelial cells. This activation leads
to the transcription of type I interferons, initiating a feed-forward loop of IL-33 signaling that contributes to
airway fibrogenesis in Lewisite/Phenyl arsenic oxide-exposed mice and persistent IFN-type I inflammation in
arsenic trioxide-exposed mice. We are investigating how a single dose of trivalent arsenic induces
mechanisms of NETs-IRF7-IL33 signaling, leading to persistent inflammation and implicating chronic lung
disorders.

Public health relevance
Narrative Lewisite, phenylarsine oxide (organic), and arsenic trioxide (inorganic) are trivalent arsenicals , that can cause neutrophilic acute lung injury. A single exposure to these arsenicals can cause neutrophilic delayed perpetuating inflammation associated lung disorders after 5 week, and 10 weeks. The current proposal investigate a common mechanism of NETs-IRF7-IL33 axis for the delayed lung injury (DLI).